APPLICATION OF RAPID FLOW MICROFLUOROMETRY TO CELL BIOLOGY

Using rapid flow microfluorometry (FMF) for analysis and sorting of cells, aspects of the following projects have been supported during the previous year: (1) the expression of IL 2 receptors on normal and malignant cells and on cells from donors treated with IL 2 or undergoing graft-versus-host disease, (2) the characterization of epidermal cells involved with generating immune responses, and (3) analysis of cells transfected with MHC genes. In addition, a user-interactive set of programs has been added to the flow cytometry laboratory to help data processing and presentation.